Dissecting the hematopoietic pathways governing age-associated pathogenic myelopoiesis

Chronic inflammation is a key factor contributing to age-related risks of tumor occurrence and progression.
Myeloid cells of the immune system, such as monocytes and macrophages, play crucial roles in maintaining
homeostasis and regulating inflammation. Besides their role in initiating the immune response, tissue-resident
macrophages (TRMs) are essential for resolving inflammation and repairing tissues. TRMs are established
during embryonic development and can persist into adulthood. However, a gradual replacement of embryonic-
derived TRMs by monocyte-derived macrophages is suspected to contribute to tissue inflammation. Our previous
research has demonstrated that myelopoiesis in response to tumorigenesis is pathogenic, with tumor-infiltrating
mo-macs impairing immune control of lung tumors. In aged mice, we found that the aging of the immune system,
independent of stromal age, drives tumor progression, and that hematopoietic aging promotes tumor-induced
myelopoiesis. Additionally, we observed that age-associated myelopoiesis correlates with the production of IL-1
alarmins in monocytes and myeloid progenitors. Blocking this pathway with the IL1R1 inhibitor anakinra
normalized myelopoiesis and promoted tumor control. However, the specific molecular mechanisms and cellular
players driving age-associated pro-tumoral myelopoiesis remain unknown. In this proposal, we aim to elucidate
these mechanisms through several approaches. We will conduct high-dimensional profiling of tumors from an
early-stage lung cancer patient cohort, perform multi-omics phenotyping of myeloid cells and progenitors from
young and aged patients as well as healthy donors, and undertake complex bone marrow experiments to isolate
and characterize the impact of immune aging on age-associated inflammation. Specifically, in aim 1 we will
identify the cellular players involved in the response to IL-1 signaling and define their role in age-associated
inflammation and tumor progression. In aim 2, we will define the central role of DNA methyltransferase 3A in
age-dependent changes in the myeloid compartment. In aim 3, we will characterize the contribution of age-
associated transposable element reactivation in the myeloid compartment to age-associated inflammation. This
proposal is the first to propose defining the cell-specific molecular pathways contributing to age-associated
pathogenic myelopoiesis. The results of this study will enable the development of new therapeutic approaches
targeting pathogenic myelopoiesis and associated inflammation in aged patients.

Public health relevance
This research aims to understand how aging affects the immune system's ability to fight cancer, particularly lung cancer. By identifying the specific ways that aging alters immune cells and promotes inflammation, we hope to develop new treatments that can improve cancer control and reduce inflammation in older adults. Ultimately, this work could lead to therapies that enhance health, extend life, and reduce illness and disability in the aging population.